National Spina Bifida Patient Registry and Urologic Management of Young Children with Spina Bifida - Component B

ABSTRACT
Spina bifida (SB) is the most common permanently disability birth defect and affects more than 166,000
Americans. Incomplete closure of the neural tube during fetal life results in impairments to multiple organ
systems including the nervous, musculoskeletal, urinary, and gastrointestinal systems. Affected individuals
can have a range of negative health outcomes such as alterations in neurocognitive development, mobility,
renal function, urinary and fecal continence, skin integrity, reproduction, and overall quality of life. The National
Spina Bifida Patient Registry (NSBPR) was developed by the Centers for Disease Control (CDC) to provide 1)
a clearer current picture of the health of SB patients across the US, 2) better describe the demographics of
Americans with SB, 3) assess the care being delivered at SB clinics both individually and collectively around
the US, 4) answer hypothesis-driven questions to assess the impact of clinical interventions upon the health
and quality of life of individuals with SB, 5) identify opportunities for future collaborative research, and 6)
develop national standards of care for individuals with SB. In the first seven years of participation in the
NSBPR, the research team at Duke has enrolled and collected longitudinal data on more than 460 individuals
with SB towards these goals. Duke clinician-scientists have been leaders in refinement and data analysis for
the NSBPR, resulting in numerous publications and presentations. This research has produced significant
insights that result in better health outcomes for individuals with SB. The continued participation of the Duke
SB clinic and their clinician-scientists in the NSBPR is needed to help achieve the laudable and obtainable
goals set forth by the CDC over the next five years. Specifically, the aims of the Duke clinician-scientists
include: 1) continued collection of longitudinal data on currently enrolled patients, 2) continued recruitment of
new patients into the registry, 3) continued refinement of definitions of urinary and fecal continence, 4)
longitudinal analysis of continence in individual patients to better evaluate efficacy of treatment modalities
including bowel management and bladder neck surgical procedures, 5) assess variations in surveillance of
renal function in patients over time, and 6) help develop and execute a smaller collaborative study of genetic
determinants of SB.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE The National Spina Bifida Patient Registry (NSBPR) was established to create a national infrastructure to support clinical research and development of a systematic approach to improve quality of care for individuals with SB. In this application, the Duke site proposes to continue to recruit participants from its unique and substantial SB patient population.